Targeting the microtubule cytoskeleton to promote cavernous nerve regeneration and erectile function after injury

Abstract
We recently published in vitro studies identifying Fidgetin-like 2 (FL2) as a novel regulator of microtubule
dynamics, with an inhibitory effect on axonal growth and nerve regeneration [1]. Since FL2-depletion had axonal
growth-promoting effects in vitro, we tested whether FL2 could be targeted to promote nerve regeneration in a
rodent model of cavernous nerve (CN) injury. The CNs are parasympathetic nerves that regulate blood flow to
the penis and are commonly damaged during the surgical procedures of radical prostatectomy (RP), resulting in
erectile dysfunction (ED). Remarkably, in these rodent models, FL2-depletion at the site and time of CN injury
led to accelerated visible nerve regeneration, accompanied by improved erectile function outcomes. However,
axonal outgrowth is only one component in the complex process of regenerating functional peripheral nerves,
which also involves recruitment and activity of multiple accessory cell-types, such as Schwann cells, immune
cells, and endothelial cells [2, 3]. In other published studies, we have demonstrated that FL2 can regulate motility
and migration of several cell types [4]. Therefore, we hypothesize that the mechanism by which FL2-
depletion promotes CN regeneration and improves erectile function outcomes following injury is multi-
faceted, involving accelerated migration of key cell types to the site of injury, in addition to enhancing
axonal growth. We will test this hypothesis using both in vitro and in vivo models and confirm that the
mechanisms of CN repair function in both young and older animals (more appropriate to the age at which men
undergo RP).
We will test our hypothesis through two Specific Aims. In Aim 1, we will determine if accelerated nerve
regeneration by FL2-depletion is associated with increased migration of Schwann cells, immune cells, and
endothelial cells to the site of CN injury and if aging affects the recruitment of these accessory cell-types. In Aim
2 we will determine the ability of targeted FL2-depletion to promote CN-regeneration, preserve penile
architecture and recover erectile function in rat models of RP.
Our research will lead to greater understanding of the underlying mechanisms by which FL2-depletion promotes
CN repair and recovery of erectile function after RP, and if aging affects these mechanisms. By understanding
these mechanisms, we will potentially identify novel therapeutic strategies not only to treat, but also to prevent,
ED following RP.

Public health relevance
Narrative Our recently published studies have identified the protein Fidgetin-like 2 (FL2) as a novel regulator of microtubule dynamics. With targeted FL2-depletion, there is accelerated nerve regeneration and improved erectile function outcomes in animal models of radical prostatectomy (RP). The present proposal expands these studies by investigating mechanisms by which FL2-depletion enhances nerve regeneration through the recruitment of cells involved in nerve repair and determining the extent to which targeted FL2-depletion improves erectile function outcomes in rat models of nerve injury.